SYNAPTIC COMPUTATIONS IN CENTRAL VESTIBULAR NEURONS

Project summary
Brainstem vestibulospinal neurons receive information about head movement from vestibular afferents, but for
unexplained reasons, during locomotion they also receive a copy of motor commands, in the form of a rhythmic
oscillation aligned with the locomotor cycle. It is unknown whether the job of this locomotor copy, known as a
corollary discharge, is to cancel the expected head movement information—thereby allowing vestibulospinal
neurons to focus on encoding unexpected head movements—or to enhance expected head movement
information, reducing the error inherent in sensory signals. Furthermore, the circuits that give rise to this
corollary discharge are undefined. Because other brainstem neurons, like reticulospinal neurons, also exhibit
these locomotor-driven oscillations, this corollary discharge signal is likely to be important in coordinating
activity between the brainstem and spinal cord more generally. The goal of this proposal is to define the
synaptic components underlying this corollary discharge, measure how sensory signals combine with corollary
discharge, and identify the presynaptic sources of this signal. In addition, completion of this proposal will
produce a synaptic-resolution map of the brainstem, broadly accessible to other researchers. Work will be
carried out in the young zebrafish, whose transparency permits accessibility to in vivo whole-cell recordings not
feasible in other vertebrates. Specific goals of this project are (1) to characterize the excitatory and inhibitory
synaptic inputs underlying corollary discharge and define how they summate with sensory input; (2) to acquire
and leverage connectomic data to identify candidate presynaptic partners carrying this corollary discharge
signal; and (3) to determine the genetic identity and function of presynaptic inputs driving corollary discharge.
This proposal relies on a combination of approaches, including whole-cell in vivo physiological recordings,
anatomical and optogenetic mapping of circuitry, and serial-section electron microscopy and reconstructions.
The project is conceptually innovative in that it seeks to define a larger-scale principle for ascending corollary
discharge carrying specific information about the locomotor cycle. The overall contribution of this work will be
to define a circuit that is widespread across vertebrates and operates at the level of coordination between the
brainstem and spinal cord for effective motor control.

Public health relevance
Project narrative Your sense of balance, which begins in the inner ear, is important to everyday life: not just when you keep your footing on a jolting train, but also when you stand up or walk. Some neurons in the brainstem get one signal from the inner ear about head movement, and another signal from the spinal cord about locomotion, but we don’t understand how these two signals are combined—or why. Here we will find exactly which spinal cord neurons the locomotion signal comes from, and determine how the balance and locomotion signals are combined.